The XPA scaffold protein in Nucleotide Excision Repair

Nucleotide excision repair (NER) protects human cells by removing harmful DNA adducts formed by
environmental toxins and solar UV irradiation. Defects in NER in humans lead to the DNA repair disorder
xeroderma pigmentosum, which is characterized by high predisposition to skin cancer, neurological
abnormalities and premature death. The repair of damaged DNA by NER also has a downside – it contributes
significantly to the development of resistance of tumors to treatment with antitumor agents, in particular cis-
and carboplatin, two of the most widely prescribed drugs in oncology.
We propose to leverage the combined expertise of the Scharer and Chazin laboratories in chemistry,
biochemistry, cell biology, structural biology, and small molecule discovery to elucidate how the scaffold protein
XPA coordinates the assembly and organization of NER incision complexes. Despite its modest size (273
residues), XPA functions as the central scaffold of NER complexes, interacting with 4 key NER proteins as well
as DNA. However, how XPA is recruited to the site of damage and positions other factors through its various
interactions remains poorly understood. Moreover, given its essential role in organizing and orchestrating the
trajectory of NER complexes, XPA is an attractive potential Achilles Heel to target for suppressing NER.
Aim 1 will test the hypothesis that TFIIH recruits XPA to sites of UV damage through a proposed interaction
interface involving the C-terminal region of XPA and the p8 subunit of TFIIH. We will biochemically and
structurally characterize this interaction and determine how mutations in the interface that disturb this
interaction affect NER in vitro and in vivo. Abolishing the interaction between XPA and TFIIH will also address
the long-standing question of whether the steps following damage recognition are the same for global genome
and transcription-coupled NER – the arrival of TFIIH and XPA is the first step common to both pathways.
The action of TFIIH on damaged DNA creates an open “NER bubble” that provides a landing platform for XPA
and RPA and is required for NER incision. The scaffolding function of XPA is reliant on its coordination with
RPA, which binds the undamaged strand. Aim 2 will determine the molecular basis and functional implications
of the coordinated action of XPA and RPA. Structural, biochemical, and biophysical approaches combined with
cellular assays will test the hypothesis that the two interaction sites between XPA and RPA are simultaneously
engaged and contribute to NER in a cooperative fashion. Based on these results, our expertise in fragment
based molecular discovery will be used to develop and validate initial inhibitors targeting XPA-RPA interfaces.
These studies are expected to provide: (i) dramatic new mechanistic insights into the central role of XPA in
assembling and coordinating the NER machinery; (ii) the identity of XPA interaction surfaces that are critical to
NER; (iii) proof of principle that interfaces between XPA and other NER factors are suitable targets for
evaluating the potential of overcoming tumor resistance to DNA damaging therapies by suppressing NER.

Public health relevance
PROJECT NARRATIVE The human nucleotide excision repair (NER) pathway is of central importance to two areas of cancer research: 1) mutations of genes involved in NER cause the inherited disorder xeroderma pigmentosum, which is associated with a 2000-fold increased incidence of skin cancer, premature death and neurological abnormalities in affected individuals; 2) processing of DNA adducts induced by radiation and chemo therapies by NER contributes to resistance to these treatments. We will investigate one central NER factor, XPA, to determine how it mediates the ordered assembly and enzymatic action of the multi-protein NER machinery. These studies will provide important new insights into to the etiology of cancer and lay the foundation to explore the potential of inhibiting NER as a means to enhance anticancer therapies.